Models for Therapy of Hereditary Retinal Degeneration

Grant EY006855 Summary
Inherited retinal diseases (IRDs) such as retinitis pigmentosa, Leber congenital amaurosis, cone-rod
dystrophy, and Best macular dystrophy are devastating blinding diseases in people. While mutations in nearly
270 genes have been associated with different forms of IRDs to date, characterization of disease mechanisms
and identification of therapeutic targets for many of these IRDs are yet to be developed. Encouraging clinical
successes with gene and cell replacement therapies have emerged in recent years for several forms of IRD in
man, and some of these treatments have resulted from proof of principle studies carried out in dog models by
our research group. At the Retinal Disease Study Facility of the University of Pennsylvania, we have an
established research capability and expertise that has allowed us to mechanistically assess over 20 canine
strains and their crosses, each of which represent different forms of naturally occurring IRDs. Using a subset of
these canine models, we aim to better understand the molecular basis and pathogenic mechanisms of these
unique IRDs and evaluate new therapies to prevent or ameliorate disease. Thus, renewal of the proposed
program will allow continued advances in translational studies using canine models of IRDs, providing a sound
basis for future development of new and effective therapies for human retinal degenerative diseases.
At our centralized resource facility, we will breed and maintain specific canine IRD strains with rigorously
characterized phenotypes/genotypes. Investigators will be provided with mutant and age-matched control dogs
either for independent or collaborative studies with investigators in academic or industry. The aim of these
studies is to understand the molecular mechanisms involved in IRDs and develop new therapies/routes of
administration that can be evaluated on a short- or long-term basis. This centralized resource will also be used
by multiple investigators to accomplish the research goals of their own NIH-funded grants. Lastly, hypothesis-
driven studies by the MPIs and collaborators will be aimed at characterizing new patient-relevant IRD models,
studying their underlying cellular/molecular mechanisms, assessing the structure of the photoreceptor
connecting cilium in disease and following therapeutic intervention, evaluating a novel molecular target as a
potential gene-agnostic approach to rescue rods, and optimizing targeting of different retinal cell types with AAVs
via a new route of administration. Our principal hypothesis is that the collaborative research using canine models
from a centralized, well-maintained resource facility, supported by a team of investigators with expertise in both
clinical ophthalmology and molecular/cell biology, will lead to critical proof-of-principle studies directed at
developing safe and effective new therapies for IRDs in patients. The proposed program and studies are
designed to fully address this hypothesis.

Public health relevance
Inherited retinal diseases that lead to devastating blinding conditions were previously considered incurable, but a handful of them can now be treated with emerging new gene and cell therapy options. However, before potential therapies can be made available for patients, it is critical that they are tested for effectiveness and evaluated for safety in appropriate clinically-relevant model systems. The research proposal aims to understand the mechanisms of genetic mutations causing retinal diseases, and to establish preclinical proof-of- principle by developing and testing new therapies that prevent or delay the retinal degeneration that leads to blindness.